Circadian Effects in the Stroke Penumbra

Circadian Effects in the Stroke Penumbra
Almost all rodent stroke research is performed in the daytime. For nocturnal rodents, this is their inactive (non-
awake) phase. In humans, more ischemic strokes occur during the daytime, and almost all patients in
neuroprotection trials are also recruited in the daytime. But for diurnal humans, this is their active (awake)
phase. We hypothesize that this “circadian mismatch” contributes to translational problems in stroke.
Our preliminary data (some published in Esposito et al, Nature 2020) suggest that: (i) neuroprotection may be
more difficult in active phase versus inactive phase stroke; (ii) the penumbra may evolve differently in active
phase versus inactive phase stroke; and (iii) vascular regulation and cell death mechanisms may be affected
by circadian rhythm. From a clinical perspective, the two important aspects of the stroke penumbra are blood
flow and infarct progression. Therefore, we will pursue 4 integrated aims to investigate circadian effects on flow
and cell death in the penumbra.
In Aim 1, we will map penumbral blood flow, metabolism, cellular response, tissue injury and behavioral
outcomes in mouse focal cerebral ischemia across the entire sinusoidal cycle of circadian rhythm. In Aim 2, we
will map the effects of cerebral ischemia on central and peripheral circadian rhythms during stroke evolution. In
Aim 3, we test the hypothesis that the circadian gene Bmal1 regulates endothelial shear stress that underlies
hemodynamic response in the penumbra. In Aim 4, we test the hypothesis that Bmal1 regulates glutamate
reuptake transporters, antioxidant gene expression, and anti-apoptotic mediators that underlie circadian
influences on excitotoxicity, oxidative stress and apoptosis.
Circadian biology affects almost all aspects of physiology, disease, and response to therapies (Cederroth et al,
Cell Metab 2019). This project may represent the first step in what should be a larger effort to re-assess
experimental stroke and neurovascular unit mechanisms with the “correct” circadian context.

Public health relevance
Circadian Effects in the Stroke Penumbra Almost all stroke experiments in rats and mice are performed during the day-time. For nocturnal rodents, this is their inactive phase. Almost all stroke patients are also recruited to neuroprotection trials in the day-time. But for diurnal humans, this is their active phase. Recently, we proposed that this “circadian mismatch” between rodent models and clinical trials may contribute to translational failure for neuroprotection. In this project, we will dissect the mechanisms that mediate circadian effects in the stroke penumbra, focusing on neuroprotection, blood flow regulation, cell death, and the exploration of novel targets in active-phase strokes.